Tracking the origin of tau pathology

ABSTRACT
The hallmark neuropathologic lesions of Alzheimer's disease (AD) are amyloid-beta (Aβ) and tau deposits.
These deposits can be observed in clinically normal adults, on average 20 years before the onset of cognitive
impairment. Despite considerable advance in imaging and biomarkers, researchers are not yet able to identify
individuals expected to accumulate pathology prior to showing any pathology. As clinical trials are moving to
earlier intervention a more accurate selection of participants at risk for accumulating AD pathology will be
crucial. The overarching goal of this proposal is to evaluate in vivo locus coeruleus (LC) integrity as a gauge
discerning cognitive aging from preclinical AD based on its very early associations with Aβ, tau accumulation
patterns and trajectories of cognitive decline. The overall scientific premise for our goal is that autopsy studies
indicated that the first tau lesions can be detected in the LC in 80% of the 40-year old cases, and LC integrity
correlates with cognition, even in persons with no pathology. The recent development of tau tracers and novel
methods to visualize the LC in detail provide now the opportunity to investigate associations between LC
integrity, age, Aβ, tau and cognition. The central hypothesis is that LC integrity can predict regional tau
accumulations and cognitive decline in individuals with lower levels of Aβ, already at midlife. Serial Aβ and tau
PET measures, serial 3T MRI, serial cognitive assessments and dedicated baseline 7T LC-MRI scans will be
collected in individuals between 36-56 years old carefully selected from the Human Connectome Project. This
data will be leveraged to another longitudinal cohort, the Harvard Aging Brain Study and our existing patient
studies. Three specific areas that could potentially identify individuals on a trajectory to preclinical AD will be
addressed: 1) to identify cross-sectional associations between age, sex and LC integrity for individuals at
different stages of Aβ and tau pathology and different cognitive impairment levels, which will contribute to the
assessment of LC integrity as a biomarker for AD pathology (Aim 1); 2) the quantification of the range of LC
integrity levels that predict regional tau accumulation and memory decline in clinically normal individuals,
which will elucidate the spatial tau patterns associated with LC integrity and may help in discerning individuals
on a trajectory of cognitive aging versus those towards preclinical AD (Aim 2); 3) to investigate underlying
mechanisms of spread of pathology by relating structural connectivity and functional activity during a sensitive
memory task to rates of tau accumulation (Aim 3). The research proposed in this application is innovative
because it moves early detection to a younger adult group (<60 years), which will provide information on the
role of LC integrity in preclinical AD and in cognitive aging. In addition, establishing potential mechanisms of
pathology progression will be relevant for the development of new pharmaceuticals. Ultimately, being able to
discern normal age-related from AD-related trajectories has a significant potential to move early detection and
intervention to time frames where Aβ is low or not yet detectable, rendering preventive trials more successful.

Public health relevance
NARRATIVE This research has important public health implications as the locus coeruleus, a small region in the brainstem that is the first site of abnormal tau protein accumulation around 40 years of age, may hold the key to discern trajectories of normal cognitive aging from those indicative of preclinical Alzheimer-disease before elevated levels of abnormal protein deposits have impacted the brain. Clinically normal adults along the adult lifespan and patients with mild cognitive impairment will be investigated using novel and established imaging techniques that allow relating locus coeruleus integrity to age, changes in cognition and changes in tau and amyloid-beta, a different abnormal brain protein. The proposed research will contribute to elucidate the mechanisms underlying progression of pathology and to move early detection and intervention to time frames where Aβ is low or not yet detectable, rendering preventive trials more successful.